R01 Administrative Supplement for AI Prediction of Trauma Resuscitation Responsiveness

PARENT R01 PROJECT ABSTRACT
The initial resuscitation of a trauma patient is often described as chaos and the clinician directing
the care must create calm while making life and death decisions often with inadequate
information. Despite some advances in understanding the biology of hemorrhage, injury still
accounts for over 5 million deaths per year, represents 1 out of every 10 deaths worldwide, and
remains the leading U.S. cause of death for those under 45. While > 90% of trauma patients do
well, the largest contribution to preventable death remains for those suffering from hemorrhage
and its related complications. Trauma has a known time zero of onset which makes it an ideal
model to study the immediate pathophysiologic changes associate with hemorrhage that lead to
differential outcome. To date, treatment pathways are considered rudimentary reflecting attempts
to optimize outcome based upon the average treatment effect, rather than being adaptable for
unique patient phenotypes. The parent R01 proposal is focused on exploring a deeper
understanding of the mechanistic modeling of initial patient response to injury (Aim 1) and
coupling this with improved real-time point of care bedside decision support technology (Aim 2)
to identify early those at risk of poor outcome. The net product of the parent proposal is to define
novel patient phenotypes that may require precision resuscitation approaches to maximize
outcome following hemorrhage. The goal of the parent R01 is to develop digital biomarkers for
precision trauma resuscitation with a focus on understanding the cross talk between the
inflammatory and coagulation profiles that occur as a systemic response to traumatic injury. The
overall goal of the parent R01 project remains unchanged and are to address limitations of our
current knowledge by improving forecasts of patient outcome trajectory at the point of care for
those suffering from traumatic injury. The parent R01 project addresses these gaps through two
interrelated aims which also remain unchanged:
AIM 1. To develop a knowledge network (neural net) approach for characterizing early
patient trajectory following hemorrhage. We hypothesize that (1A) predictive trajectories for
mortality and complications can be ascertained through deep learning approaches; (1B) the addition of
biologic data (inflammatory and coagulation markers) will further improve the prediction of patient states
or unique phenotypic patient profiles (also known as digital biomarkers) attributable to differential
outcome, and (1C) these phenotypes could be utilized to improve earlier recognition of patients off their
predicted trajectory and thus, optimize triage and treatment pathways.
AIM 2. To develop pilot prediction models for the detection of occult hemorrhage through
the integration of high fidelity, integrated point-of-care data and bedside imaging. We
hypothesize that the poor sensitivity for prediction of occult hemorrhage can be improved by developing
(2A) an automated computer algorithm using advanced machine learning to detect any free fluid in the
abdominal cavity on point- of-care sonographic images (2B) by integrating multimodality data sources
with 2A, we can predict clinically significant occult hemorrhage, and (2C) combining the imaging
prediction models with the knowledge network in Aim 1, we can develop pilot enhanced digital
biomarkers to identify patients suffering from clinically occult hemorrhage, those most likely to develop
complications, and those most likely to succumb to their injuries.
Our work to date on the Parent R01 has shown that there is differential risk of thrombotic,
bleeding, respiratory, and mortality outcomes based on initial coagulation profiles3-4. Our findings
have suggested that biology plays a major factor in distinguishing between two seemingly
identical patients who have disparate outcomes following critically injury3-19. This includes
demonstrating that severely injured patients initially suffer from bleeding due to hyperfibrinolysis,
platelet dysfunction, and disordered coagulation. Those who survive rapidly transition to a state
of hypercoagulability. The mechanisms for this remains elusive but disordered inflammatory
cytokine upregulation has been implicated and we continue to explore this in the parent R01.

Public health relevance
PROJECT NARRATIVE In the US, trauma�c injury is the number one cause of death for those under 45 years old and these deaths include many pa�ents dying from the consequences of bleeding. Through leveraging the power of ar�ﬁcial intelligence (a scien�ﬁc analysis approach similarly used in the non-medical ﬁelds to help answer ques�ons from large amounts of complex informa�on), an integrated approach to measuring outcome will be developed u�lizing biologic, clinical, and electronic medical records data. The goal of this project is to lay the ground work for developing early warning detec�ons systems that could assist in care for trea�ng pa�ents suﬀering from hemorrhage.